The genetic basis of complex traits: from yeast to humans

Project Summary
The evolutionary origins of complex polygenic traits remain an enduring enigma.
Although introductory genetics is often taught with simple monogenic examples such as
Mendel’s peas, most traits—including all common human diseases—actually result from
multitudes of interacting loci. Genome-wide association studies (GWAS) have done a
great deal to illustrate this, as well as the fact that variation in gene expression cis-
regulation—such as promoters and enhancers—accounts for most phenotypic variation.
However, uncovering the evolutionary origins of complex traits is still a major challenge.
My lab has developed experimental and computational methods to pinpoint the genes
contributing to complex traits, with a focus on evolutionary adaptations involving gene
expression regulation. Our main focus is on two methods: high-throughput precision
genome editing and allele-specific gene expression analysis in hybrids. These methods
have enabled us to implicate and experimentally validate causal genes and genetic
variants underlying complex traits in archaea, yeast, flies, fish, mice, and humans.
Moreover, the code and genetic constructs underlying our methods are freely available
to the scientific community.

Public health relevance
Narrative The main goal of our human/chimpanzee hybrid project is to improve our understanding of the genetic basis of human-specific phenotypes; this may eventually lead to deeper knowledge of the origins and etiologies of human-specific diseases such as epithelial cancers, acne, autism, schizophrenia, and Alzheimer’s disease. The main goal of our CRISPEY project is to investigate how genetic variants interact with one another (epistasis) and with the environment (GxE); this could have implications for our understanding of how genetic interactions shape complex traits such as human diseases.